Monitoring the Future: A Cohort-Sequential Panel Study of Drug Use, Ages 19-65 - Diversity Supplement (Solberg)

ABSTRACT
This application is for a diversity supplement for Dr. Marvin Solberg on the national longitudinal panel data
collections of the Monitoring the Future (MTF) study, an ongoing epidemiological and etiological substance use
research and reporting project begun in 1975 (N~120,000, 1976-2027). In addition to being a basic research
study, MTF has become one of the nation's most relied upon sources of information on trends in illicit drug,
alcohol, and nicotine/tobacco use among adolescents and young, middle, and older adults in the United States.
The MTF Panel study continues the longitudinal (web-based) surveys of nationally representative samples of
high school students (modal age 18) at modal ages 19–30, 35, 40, 45, 50, 55, 60, and now 65. The Main (school
based data collection; R01 DA001411) and Pane (R01 DA016575)l components together comprise the
integrated MTF study. MTF's broad measurement covers (a) initiation, use, and cessation for over 50 categories
and subcategories of licit and illicit drugs, including symptoms of substance use disorders; (b) attitudes and
beliefs about substances, perceived availability, and peer norms; (c) individual risk and protective factors (e.g.,
depressive affect, pro-social activities); (d) aspects of key social contexts (e.g., home, work), and social role
statuses and transitions; (e) health, social, and achievement consequences; and (f) risk and protective behaviors
related to the spread of HIV/AIDS. The cohort-sequential longitudinal design permits the measurement of factors
that may explain historical trends and cohort differences. MTF Panel is designed to document the developmental
course of drug use and related attitudes from adolescence through adulthood (ages 18-65), and to determine
the predictors and consequences of drug use across the life course. Research on risk and protective behaviors
for the transmission of HIV/AIDS is a focus of the most recent five year renewal, extending the age of monitoring
to those aged 19 to 30. Substance use by college status will continue to be tracked, totaling 45 years of annual
trend data comparing college students and non-college young adults in the U.S. The long-term follow-up also
includes data at age 65 among cohorts who were in high school during historic peaks in teen substance use and
are now facing declining health decades later. Results will continue to elucidate drug use from adolescence
through adulthood—including the use of new drugs and modalities—with important implications for national
policy, research, prevention, and treatment agendas. As our nation sees increases in adolescent and adult
vaping and marijuana use, the need to understand trends in use from adolescence to adulthood and
consequences on health, well-being, and work and family life has never been greater.

Public health relevance
NARRATIVE This application is for a diversity supplement for Dr. Marvin Solberg on the national longitudinal panel data collections (R01 DA016575) of the Monitoring the Future (MTF) study, an ongoing epidemiological and etiological substance use research and reporting project begun in 1975 (N~120,000, 1976-2027).